SUPERACTIVE GNRH TREATMENT OF PROSTATIC ADENOCARCINOMA

To determine the efficacy of GnRH in the treatment of prostatic cancer using an experimental hormone analog. Also to determine the hormonal and nutritional effects of this treatment at weeks 1, 8 and 16 of the treatment. The outcome of the treatment will be compared with that of patients treated with DES.